Investigating the pro-regenerative potential of Pontin in the heart.

Project Summary
Ischemic heart disease is the leading cause of death worldwide, in part because human heart muscle fails to
regenerate after ischemic injury. A primary barrier to human heart regeneration is the near-complete absence
of cardiomyocyte cell division following a myocardial infarction (MI). Fortuitously, injured hearts of adult
zebrafish and neonatal mice are capable of robust cardiac regeneration achieved through cardiomyocyte
proliferation. However, neonatal mice lose their innate cardiac regenerative capacity between P1 and P7 due
to cardiomyocyte cell cycle exit, the regulatory details of which remain incompletely understood. Deciphering
the pro- and anti-proliferative pathways regulating cardiomyocyte proliferation and cell cycle exit in these highly
tractable model organisms will identify druggable pathways for stimulating heart regeneration as a permanent
remedy for myocardial infarction. Herein, I propose to expand our fundamental knowledge of the gene
regulatory networks controlling cardiomyocyte proliferation through mechanistic studies on the AAA+ ATPase
Pontin and high-quality candidate downstream targets. We present preliminary data identifying Pontin as a
novel regulator of cardiomyocyte proliferation in zebrafish and mice. Zebrafish pontin mutants are devoid of
cardiomyocyte proliferation, and cardiomyocyte-specific overexpression of Pontin (pontinOECM) hyperactivates
cardiomyocyte proliferation during cardiac development, growth, and regeneration. Remarkably, Pontin
overexpression also improves the efficiency of heart regeneration, as evidenced by reduced scar size. We also
demonstrate that myocardial-specific deletion of Pontin in embryonic mice suppresses cardiomyocyte
proliferation, leading to embryonic lethality. Interestingly, Pontin levels decrease naturally in cardiomyocytes
soon after birth, consistent with the possibility that Pontin downregulation creates a barrier to regeneration by
facilitating cardiomyocyte cell cycle exit. Accordingly, cardiomyocyte-specific overexpression of Pontin delays
cell cycle exit and, potentially, expands the regenerative window. Accordingly, myocardial infarction of
PontinOECM hearts at P8 resulted in improved ejection fraction at P29, consistent with a regenerative
response. Here, I propose to test the central hypothesis that Pontin regulates cardiomyocyte proliferation by
controlling the chromatin accessibility of high-quality candidate genes identified through ‘omics efforts detailed
in preliminary data. In Aim I, we will corroborate the candidate Pontin targets regulating CM proliferation during
zebrafish heart development. In Aim II, we will corroborate the direct Pontin targets regulating CM proliferation
during zebrafish heart regeneration. In Aim III, we will determine if Pontin is a pro-regenerative factor in mice
and whether the zebrafish targets are conserved in mammals. Overall, the proposed studies will produce novel
biological insights and positively impact ongoing efforts to stimulate cardiomyocyte proliferation in the context
of human heart disease.

Public health relevance
Project Narrative The long-term goal of the proposed research is to improve the treatment of heart attacks, which are significant, costly, and growing causes of illness and death worldwide. Specifically, we propose to study how administering a novel gene therapy might stimulate permanent repair of the heart muscle damage caused by heart attacks. What we learn will improve heart attack victims' quality of life and life expectancy.